Enhancing Precision of Pediatric Cancer Molecular Targets by Aggregating CCDI Genomic Data to Pediatric Cancer Knowledgebase

ABSTRACT
Knowledge about molecular targets, including those affected by genetic abnormality, has become increasingly
critical for childhood cancer precision oncology. To facilitate exploration of genetic abnormality in pediatric
cancer, we developed PeCan (Pediatric Cancer) Knowledgebase in 2015 to establish an open access portal
for dynamic visualization of curated somatic variants from published literature contributed by St. Jude and
other institutions. PeCanV2, recently released at AACR 2023, now enables navigation of genetic abnormality,
including driver mutations and mutational signatures, in the context of ontology of ~300 molecular subtypes of
pediatric cancer. By leveraging the PeCanV2 infrastructure, we propose to enhance the precision of FDA-
approved Pediatric Molecular Target List (PMTL), characterized by the Childhood Cancer Data Initiative
(CCDI), to support clinical applications. This will be achieved by 1) developing an API to generate summary
statistics of genetic abnormality at cancer subtype level by aggregating pediatric cancer cohorts profiled by
multiple initiatives and harmonized by PeCan (Aim 1); 2) expanding the knowledgebase of pediatric cancer
genetic abnormality by integrating three CCDI data sets (i.e. CCDI MSKCC Clinical WGS, CCDI Molecular
Characterization and CCDI Metastatic Neuroblastoma), with ~9,000 pediatric cancer samples already
harmonized and curated by the St. Jude PeCan portal (Aim 2); and 3) performing mutational signature analysis
at cancer subtype level for CCDI samples profiled by whole-genome sequencing using the state-of-art
pipelines that we developed (Aim 3). Our team is comprised of researchers and software engineers who have
an established track record of leading the world’s largest pediatric cancer genomic studies and data sharing
effort. The completion of the proposed work will generate new insights into the molecular drivers of rare or
ultra-rare subtypes of pediatric cancer, while the intersection of the PMTL at molecular subtype level will
greatly enhance its clinical application. Our proposal thus addresses the key questions put forth by the RFA
and is highly relevant to the CCDI Supplement with regards to “data aggregation, linkage, integration, analysis
and visualization”, “ultra-rare tumor analysis” and “validation of the FDA Relevant Molecular Target List”.

Public health relevance
PROJECT NARRATIVE To advance precision oncology for pediatric cancer, we propose to determine targets on the FDA-approved Pediatric Molecular Target List (PMTL) for individual pediatric cancer subtypes. This will be achieved by analyzing and curating three CCDI data sets and by aggregating the results in the context of cancer subtypes with ~9,000 pediatric cancer samples on the St Jude pediatric cancer (PeCan) knowledgebase. The proposed study will generate new insight into the molecular drivers of rare or ultra-rare subtypes of pediatric cancer, enable dynamic exploration of CCDI data in the context of cancer subtypes, and provide validation of PMTL based on aggregated data generated from pediatric cancer samples.